Trimodal Vitality Imaging of Neural Progenitor Cells in the Spinal Cord

ABSTRACT
Spinal cord diseases and disorders such as spinal cord injury (SCI) and amyotrophic lateral sclerosis (ALS) are
debilitating, often resulting in loss of mobility and decreased quality of life for those affected. One promising
treatment involves the transplantation of neural progenitor cells (NPC) into the spinal cord, which has been
shown to have neuroprotective properties. However, most NPC-based therapies fail after reaching clinical trials,
and without a method to monitor the injected cells and viability, locating injected NPCs is limited to postmortem
histology. The ability to track and assess the viability of transplanted cells could be crucial in understanding
whether the failure is technical or biological in nature, such as whether the injected cells were delivered to and
remain at the correct location or survived transplantation. We propose the development of multi-modal contrast
agents and a clinical ultrasound and photoacoustic (US/PA) imaging system for image guided delivery of trans-
planted cells and longitudinal monitoring. Together with clinical magnetic resonance imaging (MRI), the use of
US/PA imaging can allow for pre-, intra- and post-operative visualization of the cells. The MRI and US imaging
modalities are well established in the clinic, and PA can be easily integrated with existing clinical US imaging
systems. We hypothesize that visualizing the location and viability of injected neural progenitor cells obtained
through the labeling of NPCs with contrast agents will allow for better understanding of transplanted cell behavior
and improved translation of cell based therapies. Two contrast agents will be developed: photo-magnetic nano-
particles, which will allow for photoacoustic and MRI tracking, and a dye-based apoptosis reporter, which will
provide photoacoustic contrast upon apoptotic activity. These will be delivered to the cytosol of the neural pro-
genitor cells and assessed for labeling efficiency and toxicity. Once optimized, labeled NPCs in different ratios
of live to dead will be injected into the spinal cords of rats to assess the feasibility of distinguishing live and dead
cells in vivo. After injection, the NPCs will be monitored longitudinally using trimodal US/PA/MR imaging. After
validating the performance of the contrast agents in vivo, a clinical US/PA imaging system will be developed to
demonstrate real-time image guided-delivery, US/PA/MRI longitudinal tracking, and PA viability assessment of
the labeled cells. The ability to monitor the transplanted cells at every point during and after the procedure will
allow for more accurate delivery of the cells and could elucidate common issues and behaviors of injected NPCs
that could lead to therapeutic improvements. Furthermore, if successful, it will validate both the contrast agents
and US/PA as a valuable tool for tracking and monitoring cell-based therapies to improve clinical translation.

Public health relevance
PROJECT NARRATIVE We propose the development of an imaging method to track and assess the viability of transplanted neural progenitor cells in the spinal cord by labeling them with two contrast agent: one that can be imaged through photoacoustic imaging and MRI and another that can signal viability through photoacoustic signal. This work will allow for a better understanding of neural progenitor cell behavior after implantation that can improve future stem cell based therapies, while establishing an imaging technique capable of monitoring implanted cells.